Targeting Tregs in the solid tumor microenvironment by modulating metabolite signaling

ABSTRACT
The efficacy of cell-based immunotherapies in treating solid tumors is hampered due to challenges
pertaining to infiltration, function, and persistence of CD8+ effector T cells. The tumor microenvironment
(TME) is designed to favor tumor survival and depletes key nutrients from the extracellular space, creating
a hostile environment unamenable to CD8+ effector function. Regulatory T (Tregs) cells can thrive in the
glucose-low TME due to their adaptable metabolic re- wiring which promotes survival of Tregs and
facilitates their suppression of effector immune cells. High frequency of Tregs in the TME is associated
with reduced response to immunotherapies, increased malignancy and poor clinical outcome.
Metabolic dysfunction in the tumor not only supports the survival of immunosuppressive cells but drives
an accumulation of metabolic byproducts that are secreted into the interstitial fluid of the TME where they
can act as signaling molecules communicating with neighboring cells, driving suppressive phenotypes.
Succinate is a critical mitochondrial metabolite that is secreted from the tumor due to an intracellular
buildup in the hypoxic conditions of the TME. We have identified that extracellular succinate promotes
the induction of Tregs from CD4+ T cells and further enhances the Th1-suppressing phenotype of Tregs.
We propose that by inhibiting the effects of succinate on Treg induction and phenotype, targeting
succinate signaling - specifically the succinate receptor (SUCNR1) - in CD4+ T cells and Tregs, we can
increase the number of tumor-specific TCR-transduced CD8+ T cells that infiltrate the solid tumor thereby
enhancing the anti-tumor response and reducing tumor burden. We will test this using tumors that have
modified succinate levels (using CRISPR/Cas9), small molecule antagonists for the SUCNR1 on CD4+
T cells and WT and SUCNR1-/- CD4+ T cells, and comprehensively assess the effects of tumor-derived
succinate on Treg induction in the TME. Utilizing our in-house high avidity TCRs that recognize the tumor
antigens MAGE-A1 and PRAME, will subsequently develop a therapeutic strategy targeting succinate
signaling to attenuate the suppressive effects of Tregs on tumor-specific CD8+ effector T cell anti-tumor
responses, using SUCNR1-/- T cells and a small molecule inhibitor targeting succinate. We will examine
this in vivo using advanced humanized mouse models (MISTRG) that support myeloid cells thus creating
an immune diverse TME. We will simultaneously use a murine melanoma immune competent model
(B16OVA OT-1) to interrogate the effects of succinate on immunosuppression on the TME. These studies
will provide a novel and innovative therapeutic strategy for combating the resident and infiltrating
suppressive Tregs in the TME and increase the efficacy of TCR immunotherapy outcomes in the solid
tumor.

Public health relevance
Solid tumors are difficult to treat with cell-based immunotherapies due to the immunosuppressive environment created by the tumor mass, in part caused by the secretion of byproducts of dysregulated tumor metabolism. We have identified that succinate, a key metabolite that accumulates in tumors and is secreted into the tumor microenvironment, promotes the induction of Tregs from CD4+ T cells, and propose to further test the effects of succinate on enhancing the suppressive phenotype of Tregs that have infiltrated the tumor, driving the suppression of effector CD8+ T cell anti-tumor responses. Targeting succinate signaling is a promising therapeutic strategy to alleviate Treg-mediated suppression of CD8+ effector T cells and enhance anti-tumor immunity and improve response to immunotherapies.